Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The goal of the Administrative Core is to support and promote the Herbert Irving Comprehensive Cancer Center’s
(HICCC) mission and strategic initiatives by providing dynamic administrative assistance to (1) the HICCC
Leadership: the Director, Deputy Director, Senior Leadership, and Internal and External Advisory Boards; (2) the
HICCC membership; and (3) the structural components that are fundamental to the HICCC’s activities, namely
the Research Programs, Shared Resources, Clinical Protocol and Data Management office, Community
Outreach and Engagement resource, and the Cancer Research Career Enhancement resource. Administrative
services include the following:
· Coordinate and oversee all administrative, communication, and fiscal activities to ensure the functionality
of the HICCC
· Oversee and coordinate the CCSG application process and CCSG reporting
· Maintain up to date information on CCSG guidelines
· Provide leadership to define and promote the mission of the HICCC throughout Columbia University and
NewYork Presbyterian Hospital, as well as with external partners
· Coordinate and manage pilot funding processes, support research development, and facilitate
collaborations
· Provide support services that facilitate increases to the research funding base and develop alliances
between the HICCC members and industry, foundation partners, and philanthropic endeavors
· Coordinate and provide support for research administration services and human resource functions to
promote a robust research portfolio and HICCC members
· Oversee the non-scientific functions of the HICCC’s Shared Resources
· Ensure efficient utilization of designated HICCC space and common equipment
· Support logistics and provide oversight for the Community Outreach and Engagement
· Provide operational assistance to oversee and fulfill the functions of the Cancer Research Career
Enhancement Core and related activities
· Represent the HICCC within the within all relevant Columbia institutional offices